Dynamic cellular architecture of bacteria by system-wide super-resolution imaging

DESCRIPTION (provided by applicant): Bacteria constitute the majority of the world's biomass and are responsible for most bioconversion on the planet. Bacterial pathogens, on the other hand, present major threats to human health, causing numerous infectious diseases in humans. Moreover, bacteria also serve as model organisms for us to understand fundamental biological processes, especially at the molecular and cellular levels. It is thus of paramount importance to understand how molecules coordinate and interact inside bacterial cells to support life processes. In bacteria, life processes take place in a small volume of <1<m3, where the chromosome and thousands of different proteins, RNA, and small molecules reside. It is now recognized that a bacterial cell is not simply a bag of enzymes, but a highly organized and orchestrated system. However, the small sizes of these cells have made it extremely difficult to probe their sub-cellular organization, due to the lack of tools with sufficient spatial and temporal resolution required to elucidate the structure and dynamics of molecular assemblies within such a small volume. Our understanding of bacterial cellular organization is thus still primitive, lagging far behind that of eukaryotic cells. For most bacterial proteins, we do not know their quantities inside the cell, nor do we know their spatial distributions and ultra-structural organization, let alone their in vivo dynamics. This knowledge deficit has severely hampered our understanding of how bacteria function. Thanks to recent developments in single-molecule detection, super-resolution imaging, and the construction of a fluorescent E. coli library in the PIs' labs, we are now in a position to have the first high-resolution, integral view of live bacteria. By combining these bioimaging and systems biology tools, we propose to quantify the entire E. coli proteome with single-molecule sensitivity, to map the intracellular distributions and ultra-structural organization of most E. coli proteins with nanometer resolution, and to follow their dynamic changes and interactions in real time in living cells. Based on such knowledge, we plan to construct a quantitative, high- resolution map of E. coli cellular architecture with the molecular specificity of each individual gene. Furthermore, we plan to profile changes of this architecture in response to cellular states and environmental conditions. This unprecedented, system-wide view of bacterial cellular architecture with ultimate sensitivity and resolution will not only address a wide range of questions in bacteriology, but will also have a broad impact on microbiology and biomedical research.

Public health relevance
PUBLIC HEALTH RELEVANCE: In this project, we propose to determine a quantitative, high-resolution map of cellular architecture of E. coli with single-molecule sensitivity, nanometer-scale spatial resolution and molecular specificity of each individual gene, and to profile changes of this architecture in response to environmental conditions with a set of bioimaging and systems biology tools. This system-wide view of bacterial architecture with ultimate sensitivity and resolution will not only advance fundamental microbiology and cell biology, but may also suggest new therapeutic targets for bacteria-based infectious diseases. The new high-sensitivity, high-resolution imaging techniques and proteomic analysis tools developed here will also have broad applications to other areas of biomedical research. Project Narrative In this project, we propose to determine a quantitative, high-resolution map of cellular architecture of E. coli with single-molecule sensitivity, nanometer-scale spatial resolution and molecular specificity of each individual gene, and to profile changes of this architecture in response to environmental conditions with a set of bioimaging and systems biology tools. This system-wide view of bacterial architecture with ultimate sensitivity and resolution will not only advance fundamental microbiology and cell biology, but may also suggest new therapeutic targets for bacteria-based infectious diseases. The new high-sensitivity, high-resolution imaging techniques and proteomic analysis tools developed here will also have broad applications to other areas of biomedical research. __SpecificAimsTextDelimiter__ In bacteria, life processes take place in a small, crowded volume of <1μm3, where the chromosome and thousands of different proteins, RNA and small molecules reside and interact. Although we now have atomic structures and biochemical details of many of these molecules, for most proteins, we do not know their cellular concentrations, nor do we know their spatial distributions and ultra-structural arrangement inside the cell, let alone their in vivo dynamics. This knowledge deficit has severely hampered our understanding of how bacteria function. Thanks to recent developments in super-resolution fluorescence microscopy, single-molecule live-cell imaging, and a fluorescent E. coli library by the PIs’ labs, we are now in a position to have the first highresolution, integral view of live bacterial cells. Capitalizing on these advances, we propose to quantify every E. coli protein with single-molecule sensitivity, map their distributions and ultra-structural organization with nanometer resolution, and follow their dynamic changes and interactions in real time in living cells. This unprecedented, system-wide view of bacterial cellular architecture with ultimate sensitivity and resolution will not only provide critical knowledge for understanding cellular processes within bacteria, but will also have a broad impact on microbiology and biomedical research. Rationale (immediately follows Impact Statement; limit for both sections together is one page): Bacteria constitute the majority of the world’s biomass. Being responsible for most bioconversion on the planet, bacteria are critical for the ecological balance of the Earth. Like a double-edged sword, bacterial pathogens also present major threats to human health, causing numerous infectious diseases in humans. Furthermore, bacteria serve as model organisms for us to understand fundamental biological processes, especially at the molecular and cellular levels. It is thus of paramount importance to understand how molecules coordinate and interact inside bacterial cells to support life processes. Such understanding will not only advance molecular and cell biology, but will also potentially benefit our society by suggesting new therapeutic targets for infectious diseases and new strategies for sustainable energy. Understanding the functional mechanisms of cellular processes depends critically on structural characterization of the cell. This is a problem that we have only begun to explore for bacteria, as it has only become appreciated recently that bacterial cells are not simply bags of homogeneously distributed enzymes, but are rather highly organized and orchestrated systems. Yet our ability to visualize bacterial cellular structures is limited by the spatial resolution of microscopy; our ability to quantify macromolecules is limited by sensitivity and specificity; our ability to monitor dynamic processes is limited by the lack of tools for real time observations of live cells. These limitations have left our understanding of bacterial ultra-structures at a primitive stage. Here we give the rationale that single-molecule sensitivity, nanometer spatial resolution, and system-wide characterization in living cells are not only necessary for understanding bacterial functions but also feasible due to recent technological advances. ¿ Single-molecule sensitivity. In bacteria, protein and RNA copy numbers vary broadly. While many essential proteins have thousands of copies in a cell, some of the functionally important proteins and most mRNAs exist at only several or fewer copies, which necessitate single-molecule sensitivity. Fortunately, fluorescent proteins (FPs) as endogenous labels1 can now be detected with single-molecule sensitivity in live bacterial cells, thanks to development of novel imaging techniques by the PIs and other researchers(2). ¿ Nanometer resolution. High-resolution views of bacteria have primarily come from electron microscopy(3), which offers nanoscopic resolution, but prohibits live-cell observation and often lacks molecular specificity. Live-cell imaging with FPs offers both molecular specificity and dynamic imaging capability, but has not provided much structural information of bacterial cells due to the small cell size and the diffraction-limited resolution of light microscopy. Recently, major advances have been made that allow fluorescence imaging beyond the diffraction limit(4). One such technique (STORM, also called PALM), co-invented by one of the PIs and other researchers(5-7), allows imaging with near-molecular-scale resolution in living cells. ¿ System-wide characterization System-wide analyses of the transcriptome and proteome have mainly relied on cDNA microarray, mRNA sequencing, mass spectrometry, and reporter libraries8. However, most of these approaches do not yet have single-bacterium sensitivity, let alone single-molecule sensitivity. We propose to construct a FP fusion library of E. coli, which will allow us to quantify the entire proteome in living cells with single-molecule sensitivity and nanometer-scale resolution when combined with the above mentioned imaging tools. By integrating these innovations, we plan to construct a quantitative, high-resolution map of E. coli cellular architecture with the molecular specificity of most E. coli proteins. Furthermore, we will profile changes of this architecture in response to cellular states and environmental conditions. We expect such a system-wide view of bacterial cells to address a wide range of questions in bacteriology, in particular problems related to chromosome organization and cytoskeletal dynamics, which are of great interest to the prokaryotic community. There is no doubt that this new set of eyes will lead to unexpected findings, generate new paradigms, and substantially advance our understanding of E. coli as a model system of microbiology and cell biology.